Biology of human cytotoxic CD4 T cells (CD4-CTLs) in viral infections

Overall Component COVID19 is a severe ongoing pandemic. Our understanding of the immune response to this disease is lacking, which impairs both the development of proper therapeutics and a vaccine. Vaccines are one of the most cost effective and extraordinarily successful medical interventions. Most of those vaccines depend on CD4 T+ cells and their help to B cells. We have developed multiple new techniques to study human CD4+ T cells over the past several years, which have have been implementing in our LJI CCHI. The supplement proposed here will facilitate rapid and vigorous pursuit of an understanding of the T cell responses to SARS-CoV2 in humans, which may help in the development of treatments and vaccines for COVID19.

Public health relevance
Overall Component It is important to understand immune responses to COVID19 disease. Our understanding of in vivo, antigen- specific human CD4+ T cell responses to pathogens remains hazy, due to the complexity of the biology, the rarity of the cells, and technical challenges of identifying antigen-specific CD4+ T cells, since they can be so heterogeneous in phenotype and cytokine potential. The overall, innovative, themes of all three Projects in the LJI CCHI are “Functional and dysfunctional T and B cell responses to infections.” We are rapidly pivoting to include COVID19 as one of the main diseases we are studying with our expertise. Dr. Alessandro Sette, one of the world’s foremost expert in T cell epitope identification, has predicted SARS-CoV2 Class I and Class II peptides for epitope identification. We will use those peptides to measure the SARS-CoV2 CD4 T cell and CD8 T cell responses in COVID19 patients. We would then rapidly move to in-depth characterization of those SARS- CoV2 CD4 and CD8 T cells by scRNASeq. Our understanding of the immune response to SARS-CoV2 in patients is lacking, which impairs both the development of proper therapeutics and a vaccine. The supplement proposed here will facilitate rapid and vigorous pursuit of an understanding of the T cell responses to SARS- CoV2 in humans by the LJI CCHI, which may help in the development of treatments and vaccines for COVID19.